Bacterial Cholesterol-Dependent Cytolysins in Inflammasome Activation

PROJECT SUMMARY
Bacterial cholesterol-dependent cytolysins (CDCs) constitute the largest group of pore-forming toxins and
serve as critical virulence factors for a wide variety of pathogenic bacteria. A number of CDCs are known to
activate the NLRP3 inflammasome, a multiprotein innate immune signaling complex responsible for induction
of proinflammatory cytokines (e.g., IL-1β and IL-18) and the proinflammatory cell death pyroptosis. Inhibition of
NLRP3 inflammasome has been shown to significantly affect bacterial dissemination and pathogenesis.
However, the detailed molecular and cellular mechanism underlying CDC-mediated inflammasome activation
has not been fully characterized. In this proposal, we propose that CDCs can be grouped into two types based
on whether they can directly remodel host organelle to stimulate the NLRP3 inflammasome signaling. This
helps the host organisms clear invading bacteria, although excessive inflammation may also result in
pathogenesis. Using a combination of SunTag live cell imaging, mass spectrometry analysis and infection
models, we aim to define the motifs and host factors responsible for CDCs to reorganize host organelle and
activate the NLRP3 inflammasome. We will also determine and characterize the abilities of Type II CDCs to
escape the inflammasome activation via inhibition of host organelle remodeling. Our proposed studies will help
define this host organelle remodeling activity of bacterial CDCs as potential broad-spectrum therapeutic targets
to mitigate a wide range of infectious diseases.

Public health relevance
PROJECT NARRATIVE Inflammasome activation by bacterial cholesterol-dependent cytolysins (CDCs) helps host organisms clear invading bacteria, although it also contributes to pathogenesis when uncontrolled hyperinflammation occurs. In this proposal we aim to define a novel host organelle remodeling activity of CDCs as an essential and broad mechanism for bacteria-induced inflammatory response. Our discoveries will advance our understanding of host-pathogen interactions and lay the foundation for rational design of antimicrobial therapeutics.